Roles of parvalbumin-expressing neurons in primate cortical processing

PROJECT SUMMARY/ABSTRACT
Inhibitory neurons likely underlie many neural computations. They are highly conserved in neural circuits
throughout the brain and their dysfunction has been implicated in many neurological and psychiatric disorders.
But very little is known about how they contribute to neural computations, especially in the primate brain. An
important computation that inhibitory neurons likely mediate is gain control. Gain control is the process by
which neural sensitivities are adjusted so firing rates stay within their dynamic ranges without altering stimulus
selectivity. Gain control exists throughout the brain, but it is especially well-characterized in the visual system,
where it can contribute to many processes such as contrast-invariant orientation tuning, attention, and
multisensory integration. A type of inhibitory neuron likely specialized for gain control is parvalbumin
expressing (PV+)-neurons. Optogenetically activating PV+ neurons in mouse primary visual cortex (area V1)
represses the responses of excitatory neurons without altering their orientation selectivity. However, it is
unknown if PV+ neurons in primates modulate their targets in the same way because of the lack of genetic
tools that enabled the mouse experiments. Fortunately, recent advances in viral genetic tools now allow for
selective targeting of PV+ neurons in macaques. In the proposed research, we will use these tools to
determine if PV+ neurons in the primate brain mediate gain control. Aims 1 and 2 are to determine if PV+
neurons are specialized for gain control by activating/inactivating them optogenetically and measuring their
effects on excitatory neurons. Additionally, many models of gain control make predictions about the tuning of
PV+ neurons. Some models predict that PV+ neurons are broadly tuned, while others predict they are tuned
similarly to their excitatory counterparts. Aim 3 is to determine which type of model is more accurate. PV+
neurons will be identified by their responses to optical stimulation, then their orientation tuning will be
compared to excitatory neurons. For all these experiments, cell-type specific optogenetics and high-density
Neuropixel recordings will be paired in primates, which will allow for extremely high-throughput characterization
of specific cell-types. This work is a crucial step towards understanding the roles of PV+ neurons in the primate
brain and how they contribute to cortical processing. This improved understanding will in turn pave the way for
future treatments of diseases associated with PV+ neurons. The proposed research will also provide valuable
training in neurophysiology, optogenetics, hardware engineering, and data analysis. Moreover, it will support
professional development by providing opportunities for scientific communication, mentorship, and teaching.
This research will be conducted at the University of Washington under the supervision of Dr. Gregory Horwitz,
who has significant experience with primate physiology and optogenetics. This work will also benefit from the
support of other faculty members and the resources of the Washington National Primate Research Center.

Public health relevance
PROJECT NARRATIVE The dysfunction of inhibitory neurons has been implicated in many neurological and psychiatric disorders, and this may be because inhibitory neurons underlie fundamental computations common throughout the brain. However, very little is known is known about how inhibitory neurons contribute to these computations, especially in the primate brain. The proposed research will determine the computational roles of one of the most common types of inhibitory neurons in primates, which will provide a foundation for future human gene therapies that rescue inhibitory neuron function.